A Mobile Health Behavioral Pain Intervention Protocol for Breast Cancer Patients with Pain in Medically Underserved Communities: A Randomized Controlled Trial

The efficacy of a mobile health (mHealth) behavioral cancer pain intervention designed to decrease pain and
disability for breast cancer patients in medically underserved areas has not been investigated. The long-term
goal of this work is to use mHealth technologies to facilitate wide-spread implementation of an efficacious
behavioral cancer pain intervention – a non-pharmacological approach to pain management. The proposed
project’s objective is to demonstrate the efficacy of an innovative mobile health Pain Coping Skills Training
(mPCST-Community) designed to meet the needs of breast cancer patients with pain in medically underserved
areas. mPCST-Community addresses intervention barriers for patients in medically underserved areas as it is
delivered with video-conferencing in the patients’ community based oncology clinic by a remote therapist, is
extended to the patients’ home environment using simple mHealth technology, and is low-literacy adapted. The
central hypothesis is that mPCST-Community will result in decreased pain compared to a mHealth education
attention control group (mHealth-Ed). The rationale of this proposal is that if mPCST-Community is shown to be
efficacious it will rapidly increase intervention access for individuals who receive their oncology care in medically
underserved areas and ultimately reduce pain-related suffering. Guided by strong preliminary data, a randomized
controlled trial will be used to pursue three specific aims: 1) Test the extent to which the mPCST-Community
intervention reduces pain, fatigue, disability, and distress, 2) Examine self-efficacy and pain catastrophizing as
mediators through which the mPCST-Community leads to reductions in pain, fatigue, disability, and distress, and
3) To evaluate the cost-effectiveness of mPCST-Community. For Aim 1, based on the study team’s extensive
work demonstrating the efficacy of in-person pain coping skills training protocols and pilot work showing promise
for mPCST-Community, it is expected that mPCST-Community will lead to decreased pain as well as fatigue,
disability, and distress compared to mHealth-Ed. For Aim 2, it is expected that the effects of mPCST-Community
will be mediated by increased self-efficacy for pain control and decreased pain catastrophizing. For Aim 3, it is
expected that mPCST-Community will demonstrate cost-effectiveness as assessed by all-cause medical
resource use, participant and therapist time, and health utilities as well as successful overall accrual, high subject
retention, and high intervention adherence. This innovative application proposes the first study to examine the
efficacy of mPCST-Community that is designed to address pain in cancer patients in medically underserved
areas. While improving access to care is critical, providing efficacious care is just as important. If mPCST-
Community is shown to be efficacious, it will provide an intervention that can be rapidly implemented into the
care of cancer patients with pain. Importantly, if efficacious this intervention could provide a needed model for
non-pharmacological approaches to pain management for other populations of patients with chronic pain.

Public health relevance
Relevance This research is relevant to public health because it aims to improve quality of life in the many US patients with cancer who live in medically underserved areas with a non-pharmacological approach to pain management. This innovative work will demonstrate the efficacy of a behavioral cancer pain intervention delivered by mHealth technology (i.e., video- conferencing with a remote therapist in the patients community based oncology clinic and home-extension with a basic smartphone) to decrease pain and disability; demonstration of efficacy has a high potential to lead to rapid wide-spread use, particularly benefiting individuals who face significant barriers (e.g., access, distance, financial, time, low literacy) to traditional behavioral interventions. The project is relevant to NIH’s mission because it aims to use a non-pharmacological approach reduce pain that incurs burden and disability and increase quality of life in patients with cancer.